The Role of the Tau in Homeostatic Scaling and Mechanisms of Alzheimer's Disease

Project Summary
Little is unknown about the mechanisms involved in the regulation of neuronal network activity by the
microtubule associated protein tau, a key pathogenic protein in Alzheimer's disease (AD). The long term goal
is to develop an independent career as a neuropathologist and a molecular neuroscientist integrating
observations from human neuropathology with molecular understanding to gain new insights into AD
pathogenesis and therapeutic strategies. This research is initially focused on how tau regulates neuronal
activity and how this regulation relates to mechanisms of AD. Preliminary studies show tau localization is
regulated by homeostatic scaling, a critical form of synaptic plasticity implicated in AD. The overall objectives
for this application are to (i) elucidate the role of tau in homeostatic scaling, (ii) define alterations in the
molecular interactions of tau during homeostatic scaling, and (iii) determine the role of homeostatic scaling in
the post-synaptic alterations of tau and AMPA receptors in culture models of AD. The central hypothesis of this
proposal is that homeostatic scaling pathways are regulated by tau and are utilized by Aβ to create post-
synaptic changes in AD. This hypothesis will be tested using live neuron fluorescent imaging of tau and AMPA
receptors, inhibition or knock-down of tau and proteins critical to homeostatic scaling, and mass spectrometry
analysis of tau interacting proteins under homeostatic scaling conditions. The rationale for this project is that
improved understanding of tau functions and their relationship to the pathogenesis of AD may lead to new
avenues of investigation for AD therapies while offering an opportunity to establish the candidate's
independence as a molecular neuroscientist. This effort will directly involve the mentorship of Dr. Richard
Huganir, an expert neuroscientist in the field of molecular mechanisms synaptic plasticity, and will take
advantage of the rich and collaborative environment of Alzheimer's disease research at Johns Hopkins
University. This work will build on the candidate's strong foundation in neurodegenerative disease pathology
and research, which will be supplemented by training in synaptic biology, imaging techniques, human induced
pluripotent stem cells (iPSCs), and biostatistical analysis, areas critical to the proposed work and to future
investigations. The proposed research is innovative because it defines novel roles and interactions of tau
regulated by neuronal activity, and it directly tests the contribution of homeostatic scaling to AD-related
synaptic changes. The proposed research is significant because it will provide insight into novel biologic
functions and interactions of tau, and their relationship to AD pathogenesis. Ultimately, knowledge of these
mechanisms may elucidate of the contribution of tau to sporadic AD and lead to novel therapeutic strategies.

Public health relevance
Project Narrative The proposed research is relevant to public health because it investigates the normal and disease-related functions of tau, a key protein involved in Alzheimer's disease. This research will contribute to our knowledge of mechanisms of sporadic Alzheimer's disease and may lead to new therapeutic strategies to treat this devastating disease. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to seeking knowledge about the behavior of living systems and application of that knowledge to reduce illness and disability.